CORE--GLASSWARE WASHING AND STERILIZING FACILITY

The Glassware Washing and Sterilizing Facility located on the first floor of the McArdle Laboratory does the glassware washing and autoclaving for all of the investigators in the McArdle Laboratory. Dr. William Fahl is the faculty supervisor of this Facility, and Ms. Karen Schwarz oversees the sen to ten employees in the Facility. Washing and autoclaving procedures are established for each of the research groups. Materials are picked up from the laboratories, washed and/or autoclaved in the first-floor facility, and returned to the laboratories. I general, this involves an average two- to three-hour turnaround for pickup, washing, and delivery of the clean material. This rapid turnaround allows up to minimize the cost and space required for maintaining large glassware inventories in laboratories. In addition, other special procedures, including special cleaning agents, ultrasonic cleaning of pipettes, acid washing, rinsing with deionized water, etc., are performed as necessary, especially for the cell culture laboratories. These are five autoclaves, each of which is devoted to a specific application based upon the sophistication of the autoclave and the type of steam it uses for the autoclave cycle; these applications include autoclaving large numbers of media bottles for tissue culture media, pipettes, selected pieces of laboratory glassware, large volumes of bacterial media, as well as the routine decontamination of tissue culture and bacterial waste.